2022 Frontal Cortex Gordon Research Conference

Abstract
The prefrontal cortex (PFC) is involved in all aspects of cognition and behavior and has established roles in all
forms of mental illness and substance use disorders. The PFC has been studied intensely over the past four
decades. Interest in studies of the PFC in animal models has grown at a pace equal to that of human studies on
the PFC. Surprisingly, no established meetings exist that focus on the PFC and bring together researchers using
different animal models (non-human primates, rats, mice) and a variety of experimental approaches (e.g.,
lesions, pharmacology, anatomy, physiology, molecular tools, computational models). A new Gordon Research
Conference (GRC) on the Frontal Cortex has been established to provide a forum for researchers interested in
the PFC and related cortical areas (e.g., OFC). The GRC will convene in Ventura, CA in August 2022. It is our
hope that financial support can be obtained from the NIH to support the meeting. Support from NIH will allow us
to offset the attendance costs of our invited speakers and trainees, especially from underrepresented groups.
We propose the following Aims: (1) To convene a diverse scientist workforce around fundamental questions in
research on the frontal cortex. The conference will feature panels on fear/aversive and reward/appetitive
learning, which to our knowledge have not been discussed together at other meetings, and comparative
neuroanatomy, a topic that is crucial for relating preclinical findings to current research in human populations.
(2) To unite a diverse scientist workforce around emerging technologies in frontal cortex research. Panels will
discuss the use of powerful tools such as optogenetics, chemogenetics, and calcium imaging and how they can
be used to link studies in mice and rats to findings from studies in humans and non-human primates. (3) To
promote the development of women scientists, early-career researchers, and under-represented investigators
in frontal cortex research. We will host a networking and mentoring PowerHourTM focused on negotiation across
career stages.

Public health relevance
Narrative A new Gordon Research Conference (GRC) on the Frontal Cortex has been established to provide a forum for researchers interested in the prefrontal cortex, related parts of the frontal cortex and their functions across species. The GRC will convene in Ventura, CA in August 2022. We plan a diverse meeting to include trainees from under-represented groups.